A Randomized Controlled Trial Examining Extended-Injectable Buprenorphine in those who use High Potency Synthetic Opioids

Project Summary
Opioid use disorder (OUD) presents a serious public health problem despite available and effective medications
for OUD (MOUD). One factor complicating treatment delivery for OUD and contributing to a devasting overdose
(OD) crisis is the proliferation of high potency synthetic opioids (HPSO). HPSO are mu opioid agonists estimated
to be 50-1000 more potent to morphine that have become increasingly common in illicit drug supplies over the
past several years. Despite the ubiquity of HPSO, systematic evaluations of treatment outcomes for those with
OUD who use HPSO remain sparse. Further, factors influencing HPSO physiological dependence and
withdrawal, and potential biomarkers (body weight, body fat percentage, plasma
buprenorphine/norbuprenorphine levels) contributing to individual differences in response to HPSO remain
understudied. There is therefore an urgent need to optimize MOUD use in the context of HPSO and enhance
understanding of how individual differences in response to HPSO influence clinical outcomes. The use of
extended release, injectable buprenorphine (INJ) may improve treatment adherence and confer greater
protection from HPSO-related OD compared to sublingual buprenorphine/naloxone (SLB). However, this
approach remains understudied in this population. GOALS: The primary objectives of this K23 Mentored Patient
Oriented Research Career Development Award proposal are to: Compare abstinence and relapse rates
among those with OUD who use HPSO randomized to receive INJ versus SLB during a 2-day inpatient
induction (Aims 1a and 1b), Examine the effect of quantitative HPSO level on admission on opioid
withdrawal symptoms and dropout during the induction period and (Aim 2), and Explore the relationship
between plasma buprenorphine/norbuprenorphine levels on craving, withdrawal, and time to first use
(Exploratory Aims). DESIGN: Forty adults with OUD who use HPSO will be admitted for a 2-day inpatient
induction period. Following admission on day 1, a COWS score ≥ 6 will prompt administration of 4/1mg SLB.
One hour after tolerating this dose, participants will be randomized to receive 1) a 300 mg extended-release
buprenorphine injection (INJ; n=20) or 2) or a placebo injection followed by continued titration onto SLB (SLB;
n=20). Quantitative HPSO levels (urine derived LC-MS) will be collected on admission. Following discharge,
participants will be scheduled for 1-, 2-, 3-, 4-, 8-, and 12-week follow up visits. We hypothesize that the INJ
group will have a higher percentage of days abstinent and lower proportion of participants with a sustained
relapse than the SLB group across follow up. Further, we hypothesize that quantitative HPSO level on admission
will be positively associated with withdrawal severity and dropout during the induction period for both groups. In
completing the proposed study, I will gain invaluable training and experience towards my career development
goal of becoming an independent clinical researcher.

Public health relevance
PROJECT NARRATIVE The presence of high potency synthetic opioids (HPSO) in illicit opioid and other drug supplies presents a grave public health crisis and appears to be compromising the use of available treatments for those with opioid use disorder (OUD). Despite the ubiquity and persistence of HPSO, systematic evaluations of treatment in the HPSO era remain sparse and HPSO physiological dependence and withdrawal remain poorly characterized. Based on this gap in the literature, the primary goals of this mentored research development proposal are to compare buprenorphine formulations among those with OUD who use HPSO and to better characterize factors influencing successful initiation of and retention in treatment with an emphasis on quantitative HPSO levels and biomarkers (body weight, body fat percentage, and plasma buprenorphine/norbuprenorphine levels).